A phase I/II combination immunotherapy clinical trial: mesothelin-targeted chimeric antigen receptor T cells and checkpoint blockade agent in pleural mesothelioma

PROJECT SUMMARY/ABSTRACT
Malignant pleural mesothelioma (MPM) is a rare cancer with poor prognosis. There have been no FDA-
approved therapies for MPM patients since 2003. Patients with MPM who present with high levels of cytotoxic
tumor infiltrating lymphocytes (TILs) have better survival. To promote TILs in MPM, we developed an adoptive
T-cell therapy using chimeric antigen receptors (CARs). We have developed and translated mesothelin
(MSLN)–targeted CAR T cells to phase I clinical trials (NCT02414269 and NCT02792114). MSLN is a cell-
surface antigen highly expressed in MPM, with very low expression in normal tissues. In our two clinical trials,
no on-target, off-tumor toxicities were noted among 28 patients treated so far. CAR T cells are
administered intrapleurally in NCT02414269, on the basis of our published data (Sci Transl Med 2014) that
established regionally administered CAR T cells potentiate antitumor efficacy by augmenting CD4 T-cell helper
function. Beyond safety, promising antitumor efficacy has been observed in our phase I trial of intrapleural
CAR T cells. Following administration of a low dose of CAR T cells, tumor cells upregulate PD-L1/L2 and
inhibit T cells via binding to PD-1. We have shown that administration of anti-PD-1 agents can overcome
tumor-mediated adaptive resistance and promote CAR T-cell functional persistence (J Clin Inv 2016).
Supported by these data, we treated 11 of 18 MPM patients with pembrolizumab, an anti-PD-1 agent, and
noted no adverse events, and enhanced persistence of CAR T cells and antitumor efficacy.
Building on these strong data, we propose an investigator-initiated phase I/II clinical trial combining
CAR T-cell therapy with pembrolizumab. We hypothesize that cancer antigen-targeted CAR T cells can
promote TILs and that anti-PD-1 agent can combat adaptive resistance by reversing exhaustion of both CAR
and endogenous T cells. We will determine the safety of adoptive transfer of genetically modified, autologous,
MSLN-targeted T cells into the pleural cavity of MPM patients (with previous administration of
cyclophosphamide), followed by treatment with pembrolizumab until tumor eradication or toxicity (Aim 1). The
primary endpoint is to determine the safety and maximum tolerated dose (MTD) of MSLN-directed CAR T cells
in combination with pembrolizumab (phase I) and to estimate the response rate of the combination therapy
(phase II). We will analyze serially collected pleural fluid, tumor biopsy specimens, and peripheral blood to
assess the ability of PD-1 blockade to reverse CAR T-cell exhaustion (Aim 2) and activate antitumor
endogenous immunity (Aim 3), compared with treatment with pembrolizumab alone. Investigating regional
versus systemic endogenous and CAR T-cell immunity following activation with anti-PD-1 agent, compared
with anti-PD1 agent alone, is mechanistic, innovative, and translational. The ensuing results are directly
applicable to 150,000 patients with pleural metastatic tumors (from MSLN+ve lung and breast cancers) and
extendable to more than 2 million patients with MSLN-expressing solid tumors per year in the U.S. alone.

Public health relevance
PROJECT NARRATIVE This is a phase I/II clinical trial to assess safety and efficacy of combination immunotherapy (Aim 1) of malignant pleural mesothelioma treated with autologous chimeric antigen receptor T cells genetically engineered to target mesothelin followed by pembrolizumab, an anti–PD-1 checkpoint blockade agent. We will analyze serially collected samples to assess adoptive (Aim 2) and endogenous immunity (Aim 3). Assessing the ability of checkpoint blockade to restore adoptive and endogenous T-cell function will advance our understanding of the immune response.